IMPACT OF TUBERCULOSIS ON THE HIV RESERVOIR

PROJECT SUMMARY
Even though antiretroviral therapy (ART) can suppress HIV and increase life expectancy, it does not provide
cure. Patients must commit to daily medications and deal with side effects, unsustainable costs and drug
resistance. The main obstacle to an HIV cure is persistent provirus in the resting CD4+ T cell reservoir which
produce virus under the right stimulation conditions. The most popular approaches for HIV cure or remission
such as the shock and kill approach, broadly neutralizing antibodies, chimeric antigen receptors and therapeutic
vaccines will all require some form of reactivation of the latent provirus.
However, tuberculosis, an important factor that could affect the viral reservoir and its response to latency
reversing agents (LRAs) has not received much attention in the context of HIV cure research. Over a third of HIV
patients are infected with TB. Tuberculosis, including latent TB infection (LTBI), produces antigens that stimulate
T cells, which could result in proliferation and alter the response of the reservoir to LRAs. Persistent stimulation
could also result in T cell exhaustion.
We are working with the hypothesis that TB antigens in the blood of co-infected patients stimulate T cells to
increase the size of the reservoir and alter the responses of CD8+ and CD8+ T cells. We will investigate this
hypothesis with the following specific aims:
Aim 1: Identify differences in T cell responses between HIV and HIV/LTB patients. We hypothesize that in co-
infected patients, CD4+ T cells will have decreased responses to LRA and CD8+ T cells will have reduced killing
ability upon stimulation. First, we will compare the baseline activation status of resting T cells from virologically
suppressed patients (VL <50 copies per ml) with HIV or HIV/LTBI. Second, we will stimulate the CD4+ and CD8+
T cells in each group for the production of relevant cytokines and the expression of the activation and exhaustion
markers. Third, we will isolate resting T cells from patients and stimulate them with different LRAs. Fourth, we
will determine the capacity of CD8+ T cells from co-infected patients to kill reactivated CD4+ T cells expressing
HIV-1 antigens.
Aim 2: Determine the size of the HIV reservoir in HIV only and HIV/LTB co-infected patients. We hypothesize
that co-infected patients will have a larger reservoir size due to persistent stimulation that results in further CD4+
T cell seeding or clonal expansion. We will recruit 75 HIV only patients and 75 HIV-TB patients from our cohort
with a viral load of <50 copies per ml for more than 2 years. We will isolate resting T cells to measure the size of
the reservoir using the IPDA assay which measures only intact proviruses with potential to produce virus.
This project will provide critically missing knowledge and understanding of how T cells in patient co-infected with
TB respond to latency reversing agents, and give an indication on the size of the HIV reservoir in these patient.
Information gained will be crucial in planning HIV cure studies in co-infected patients.

Public health relevance
PROJECT NARRATIVE Most of the methods being developed to obtain a cure or permanent remission for HIV depend on the ability to reactivate the latent provirus. An important factor that could determine whether CD4+ T cells are amenable to reactivation is the presence of tuberculosis antigens in the blood of patients. Since over a third of HIV patients are co-infected with TB, this proposal seeks to determine how tuberculosis antigens impact the size of the HIV reservoir and responses of CD4+ T cells to latency reversing agents.